Innovations for screening and prognosis in HIV+ cancers including Kaposi sarcoma, cervical cancer, and lymphoma in Malawi and South Africa

ABSTRACT: OVERALL COMPONENT: Innovations for screening and prognosis in HIV+ cancers
including Kaposi sarcoma, cervical cancer, and lymphoma in Malawi and South Africa
In response to RFA-CA-20-001, this application proposes to establish the UNC-Malawi-South Africa Cancer
Consortium (UMSACC), to develop capacity and conduct high-impact research focused on HIV-associated
cancers. The consortium builds on longstanding collaborations between the University of North Carolina at
Chapel Hill, Lighthouse Trust in Malawi, Malawi Ministry of Health, Malawi College of Medicine, the University
of the Witwatersrand, South Africa, and Stellenbosch University, South Africa. These partnerships have been
made possible by leadership and participation in NIH networks conducting basic, clinical and epidemiologic
research in the region. These existing relationships and robust infrastructure can now be leveraged for HIV-
associated malignancies, which are overwhelming contributors to cancer burden in Malawi and South Africa
even after widespread antiretroviral therapy usage. UMSACC is focused on the three most common HIV-
associated cancers, Kaposi sarcoma (KS), cervical cancer, and lymphoma, and addresses the NIH HIV/AIDS
research priorities by focusing on HIV-associated comorbidities which includes these AIDS-defining cancers.
UMSACC proposes innovations for screening and prognosis of these cancers in persons living with HIV
(PLWH) with the overall goal being to improve the health of PLWH.
Our consortium will be led by principal investigators with highly complementary expertise using a team science
approach. To support consortium objectives, a diverse team of investigators has been assembled spanning the
clinical, population, and basic sciences, and includes Malawian, South African, and US scientific leaders.
Moreover, a high priority is the training and support of junior investigators in the U.S. and Africa. The
consortium will enhance existing administrative, operational, and research relationships between all partnering
institutions and investigators. The External Advisory Board and Scientific Advisors will ensure that the
consortium remains highly responsive to community needs in Malawi and South Africa, while also addressing
urgent research questions facing the international HIV-associated cancer community.
A focus of this consortium is to develop Malawi and South Africa to become international leaders in HIV-
associated cancer research. Building on prior successes and partnerships outlined in this application,
UMSACC is extremely well-positioned to catalyze a broad, coordinated, cancer control effort in Malawi and
South Africa, and to advance the overall NCI scientific agenda for sub-Saharan Africa to reduce HIV-
associated cancer burden in low- and middle-income countries.

Public health relevance
PROJECT NARRATIVE: OVERALL COMPONENT: Innovations for screening and prognosis in HIV+ cancers including Kaposi sarcoma, cervical cancer, and lymphoma in Malawi and South Africa In response to RFA-CA-20-001, this application proposes to establish the UNC-Malawi-South Africa Cancer Consortium (UMSACC), to develop capacity and conduct high-impact research focused on HIV-associated cancers. Our consortium will be led by principal investigators with highly complementary expertise using a team science approach and a high priority of the consortium is the training and support of junior investigators in the U.S. and Africa. UMSACC proposes innovations for screening and prognosis of Kaposi sarcoma, cervical cancer and lymphoma in persons living with HIV (PLWH) with the overall goal being to improve the health of PLWH.